Administrative Core

SUMMARY
The proposed Administrative Structure for the RCMI Center at the Ponce Health Sciences University (PHSU)
will utilize the multi-Pl option. Drs. Jose A. Torres-Ruiz and Richard Noel will serve as PIs with a combined time
and effort of 50%. Both PIs are well respected academic leaders and have complementary expertise needed for
the effective day-to-day management of the RCMI Center at PHSU. Dr. Torres-Ruiz is fully acquainted with the
goals and objectives of the RCMI Center as he has served as the Contact PI since 2006. He is an experienced
and accomplished investigator and mentor and has substantial administrative experience. He has been in the
faculty at PHSU for 35 years, and during his tenure, he has occupied numerous leading administrative positions
including the Deanship for Research and Graduate Studies. As the Contact Pl, his duties and responsibilities
include; overseeing the day-to-day management of all Core activities generated through the Center; facilitating
and coordinating the duties of the institutional RCMI advisory units, implementing the proposed RCMI Faculty
Recruitment Program, implementing the proposed assessment plan, promoting the development of Research
Partnerships and Collaborations between PHSU and other research-intensive institutions, and overseeing the
implementation of the proposed Professional Development activities. Dr. Richard Noel, the other PI, an
experienced and accomplished administrator, will be responsible of coordinating and implementing the proposed
Professional Development Program that will be undertaken to support career enhancement for post-doctoral
level professionals and junior faculty from a variety of disciplines and overseeing the establishment and
development of the proposed three full research projects included in the current application. Mrs. Doris Andujar
will continue serving at the Executive Manager of the RCMI Center. Activities under the Administrative Core will
be assessed by the RCMI Internal and external Advisory Committees, as well as by an External Evaluation
Team. The Evaluation team will oversee and conduct a comprehensive evaluation plan to facilitate Center`s
performance and project management to ensure the successful completion of the proposed aims. The
administrative Core Team will continue establishing partnerships and collaborations with the RCMI Coordinating
Center, and with programs at RCMI as well as non-RCMI institutions in the Nation. All of these efforts seek to
promote the establishment of additional research and training opportunities to investigators at our RCMI Center.
Moreover, the Administrative Core will support the design and implementation of a series of didactic activities
(seminars, workshops, courses, etc.) to promote the field of health disparities.

Public health relevance
The Administrative Core (AC) of the PHSU RCMI Center plays a critical role in strengthening institutional research capacity and ensuring the effective coordination, management, and evaluation of all Center activities. By supporting investigator development, nurturing strategic research partnerships, and facilitating access to shared resources and professional training, the AC improves the quality and impact of health-related research. These efforts contribute to the generation of scientific knowledge and evidence-based strategies that improve understanding of differences in health outcomes and inform practices and policies aimed at improving population health.